FQHC Intervention for CGM Uptake in Adults with T1D

Low-income adults with type 1 diabetes (T1D) face a high risk for life-threatening, acute complications with increased rates of related emergency department visits, hospitalizations, and death. Use of continuous glucose monitoring (CGM) helps mitigate T1D complications. Yet, low-income adults with T1D have exceptionally low levels of CGM use. This reflects social determinants of health (SDOH), as framed by the Socio-Ecological Model (SEM). Following SEM, healthcare is a main driver in limiting access to CGM. With a severe shortage of endocrinologists, primary care providers (PCPs), including Federally Qualified Health Center (FQHC) PCPs, are increasingly managing T1D. Although PCPs are filling a gap in T1D care, they often lack proficiency in integrating CGM into clinical practice with most reporting inadequate confidence in using CGM and insulin titration. At FQHCs (90% low-income patient population), CGM prescriptions are often infrequent for patients with T1D although it is an American Diabetes Association standard of care.
To foster uptake of CGM in low-income adults, we will partner with FQHCs in conducting a 4-year, mixed-methods, feasibility study with a pilot randomized controlled trial (RCT). FQHC adult patients with T1D and at or below the federal poverty level will be sampled. Informed by SEM, the intervention targets the individual, family/social networks, and healthcare provider levels. The individual level of the intervention fosters acquisition of information, motivation, and behavioral skills for CGM uptake through sessions led by a RN diabetes educator and peer educator, respectively. The family/social networks level leverages social support with a family member co-attending the 4-week RN sessions and participant engagement with a peer educator over six months. The provider level provides rigorous clinical support for CGM via Project ECHO.
In study phase 1 (Aim 1), the intervention be refined, informed by stakeholder qualitative findings. Study deployment will be planned with randomization of 9 FQHC sites to deliver the intervention (n=6) or control (n=5) conditions with a total enrollment goal of 30 adults with T1D. Project ECHO programs will be delivered to intervention (T1D Care + CGM) and control (T1D Care) site providers, respectively.
In study phase 2 (Aim 2), feasibility of the study protocol (e.g., recruitment and retention yields, data collection, intervention implementation, among others) will be assessed routinely. In phase 2 (Aim 3), significant intervention signals in terms of physiological (A1C and CGM metrics), psychosocial (e.g., quality of life, family support, physician trust), and behavioral (CGM adherence) outcomes from baseline to 3- and 6-months post-baseline will be assessed across the sample, including analyses for racial/ethnic subgroups with >12 participants. Findings will guide a fully powered, multi-site RCT to inform a FQHC model of care for CGM uptake in adults with T1D.

Public health relevance
Low-income adults with type 1 diabetes (T1D), despite their disproportionate burden of acute complications and related emergency department visits and hospitalizations, remain largely disenfranchised from continuous glucose monitoring (CGM), an efficacious technology shown to mitigate T1D complications. To increase CGM uptake in low-income adults with T1D receiving diabetes management in Federally Qualified Health Centers (FQHCs), the proposed mixed-methods study, with a pilot randomized control trial (RCT), will assess the feasibility of our study protocol, including our multi-level intervention informed by the Socio-Ecological Model. If the proposed multi-level intervention is found to be feasible and RCT findings indicate the intervention, relative to the control condition, shows promise, we anticipate a large-scale, multi-site RCT to follow to provide rigorous evidence in favor of our CGM intervention model to improve T1D outcomes in low-income adults receiving diabetes care in FQHCs.